Neurosteroid Intervention for PTSD in Iraq/Afghanistan-era Veterans

There is an acute and urgent need to develop new and effective pharmacological interventions for
posttraumatic stress disorder (PTSD), as there are currently only two FDA-approved medications for the
treatment of PTSD (both of which are from the same drug class and have shown only moderate effect sizes in
FDA registration trials). Many Veterans with PTSD thus remain symptomatic despite the availability of these
treatments, increasing the likelihood of receiving pharmacological treatment interventions for which there is
little or no empirical evidence. Randomized controlled trials (RCT) utilizing new medication approaches are
thus acutely needed in the Iraq/Afghanistan-era Veteran population, a cohort that may be less treatment-
refractory (particularly if treated early in the course of PTSD symptom development). The investigation of
promising pharmacological agents for this Veteran cohort could thus not be more timely or urgent.
Increasing evidence supports a potential role for neurosteroids in the neurobiology and treatment of PTSD. For
example, allopregnanolone (a downstream metabolite of pregnenolone) has anxiolytic, antidepressant, anti-
aggressive, fear-reductive, neuroprotective, anti-inflammatory, and neurogenesis-enhancing actions – and
these properties could have clear therapeutic utility for PTSD. Our preliminary data also demonstrate that
serum allopregnanolone levels are significantly decreased in patients with PTSD compared to control
participants in two independent cohorts. We have shown in multiple studies that pregnenolone administration
elevates downstream allopregnanolone levels 5-10 fold, and can thus potentially serve as a precursor loading
strategy to restore deficient allopregnanolone levels in PTSD. Furthermore, recent neuroimaging studies
demonstrate that allopregnanolone plays a role in the modulation of brain function associated with negative
emotion, and enhances activity associated with emotional regulatory processes (Sripada, 2013; Priority
Communication, Biological Psychiatry). In addition, our preclinical rodent models demonstrate that pre-
treatment with pregnenolone mitigates anxiety-like behaviors in rodents following predator stress exposure.
Finally, we have demonstrated that PTSD symptoms improve in Veterans with mild Traumatic Brain injury
(mTBI) following administration of pregnenolone in both a pilot RCT and in a larger follow-up RCT in mTBI. In
both studies, Veterans with mTBI randomized to pregnenolone showed marked elevations in serum
allopregnanolone and pregnenolone levels post-treatment. A precursor loading strategy to enhance deficient
levels of endogenous allopregnanolone may thus be an efficacious treatment for PTSD. We therefore propose:
1.) To investigate the potential efficacy of pregnenolone to treat PTSD in Iraq/Afghanistan-era Veterans by
conducting an RCT of pregnenolone vs. placebo (primary endpoint CAPS-5 change; [90 randomized
participants; n=45 per group;] 8-week duration of treatment),
2.) To determine if pregnenolone also improves co-occurring pain and depression symptoms (secondary
endpoints Brief Pain Inventory and Hamilton Depression Rating Scale),
3.) To quantify serum neurosteroid levels at baseline and post-treatment to determine if pregnenolone and
downstream neurosteroid metabolites such as allopregnanolone (and other biomarker candidates such
as inflammatory markers) are predictors of therapeutic response.
Results of the proposed RCT could provide the scientific foundation for the potential efficacy of pregnenolone
in PTSD and lead to a pivotal Phase III study. Clinical and preclinical data support the possible therapeutic
utility of pregnenolone for PTSD symptoms, pain disorders, and depression, and pregnenolone has been very
well-tolerated in Veteran cohorts to date. Treatment with pregnenolone could thus represent a promising new
intervention in PTSD that is efficacious, inexpensive, and safe in Iraq/Afghanistan-era Veterans.

Public health relevance
There are currently only 2 FDA-approved medications for the treatment of PTSD, both of which were approved more than 15 years ago and resulted in only moderate-effect sizes in FDA registration trials. The development of effective pharmacological treatments for Iraq/Afghanistan-era Veterans with PTSD is especially urgent, as Veterans returning from deployments experience high rates of PTSD often resulting in debilitating symptoms and reduced quality of life. Converging data suggest that pregnenolone is a promising pharmacological agent for treating PTSD symptoms. We thus propose to conduct a randomized clinical trial investigating the potential efficacy of pregnenolone for PTSD and commonly co-occurring symptoms such as pain and depression. Pregnenolone has a favorable side-effect profile, and our prior research demonstrates that pregnenolone is well-tolerated in Veteran cohorts. Treatment with pregnenolone could thus be an efficacious, inexpensive, and safe new therapeutic for Iraq/Afghanistan-era Veterans with PTSD.